Maternal-Fetal Medicine Units Network

ABSTRACT
During our 3 cycles in the MFMU Network, we demonstrated the ability of our clinical and research
infrastructure at The University of Texas Medical Branch (UTMB) to effectively contribute to multisite trials. In
addition to productivity in the MFMU Network, the PI, George Saade, and alternate PI, Luis Pacheco, bring
extensive experience in study design, recruitment, data analysis, and publications from several non-MFMU
Networks, such as the Stillbirth Collaborative Research Network and Genomic/ Proteomic Network for
Premature Birth Research. We achieved successful patient recruitment and retention through our
Department’s Regional Maternal & Child Health Program (RMCHP). RMCHP clinics, following protocols set by
the Maternal-Fetal Medicine Division, provide prenatal care for more than 9,000 multiethnic pregnant women
annually. We deliver more than 5,000 pregnancies a year—many of them high risk—with more than 90%
receiving prenatal care in our system. The Department's Electronic Medical Record System (EMR) captures
antepartum and intrapartum data online and is readily available to authorized research personnel for query as
well as automatic notification. The EMR and policies/procedures have been successfully adapted to maximize
our research productivity. The MFM Division and team of dedicated research staff in the Perinatal Research
Division (PRD), all under the direction of the PI, have broadened efficiency in clinical investigations. Ashley
Salazar, MFMU Research Nurse Coordinator, brings extensive experience and expertise to the team. The
collaborative relationship among the PI, the Department Chair, and the RMCHP Medical Director offers further
benefit and efficacy to the Network. As the chief of OB, the PI directs the medical management of all
Obstetrical patients at UTMB. Our Department has a well-funded basic science research group with expertise
in many areas of relevance to the RFA. Finally, we have well-established collaborative ties with our University's
Divisions of Neonatology, Genetics, Perinatal Pathology, Clinical Laboratory, and Radiology. At all levels,
UTMB emphasizes research in general, with multiple core facilities available to the Network, including the
Institute of Translational Research, the home for UTMB’s CTSA. Our Department is consistently one of the top
NIH-funded Ob/Gyn departments in the nation. We accept the RFA’s capitation and participatory stipulations
and stand ready to continue as productive members of the Network.

Public health relevance
NARRATIVE Investigations by the MFMU Network focus on problems in clinical obstetrics, particularly those related to prevention of low birth weight, prematurity, and medical problems of pregnancy. These complications can lead to health problems at birth as well as later in life; therefore, research that may lead to their prevention has powerful potential for improving individual lives and public health.